Developing Combination Therapies against Pneumo- and Paramyxoviruses Causing Severe Respiratory Infection

It is the overarching hypothesis of this project that long-term therapeutic success against human
parainfluenzavirus type 3 (HPIV3) and respiratory syncytial virus (RSV) will require a combination therapy
approach with a pair of pathogen-directed inhibitors with distinct mechanistic profile. This notion is driven by
the strict safety profile requested by a mostly pediatric patient population and the threat that resistance
mutations against individual therapeutics may become fixed rapidly in circulating virus strains. Members of the
closely related paramyxo- and pneumovirus families, HPIV3 and RSV are responsible for the majority of
severe lower respiratory infection (LRI) and death from viral disease among infants in the United States, and
recognized as a potential threat to the immunocompromised and the elderly. Infection by both pathogens
initiates in the upper respiratory epithelium, followed by gradual progression to the small airways in patients
advancing to severe disease, opening a window for therapeutic intervention. No vaccine protection or effective
therapeutic is currently available against either HPIV3 or RSV, and antibody immunoprophylaxis against RSV
is restricted to a subset of high-risk patients. This project will address this unmet clinical need by developing
applicable, cost-effective therapeutics targeting the viral RNA-dependent RNA polymerase (RdRp) complexes.
Building on an established antiviral program, we have recently identified an efficacious nucleoside analog
inhibitor with potent activity against both RSV and HPIV3. Serving as reference, this compound will inform the
co-development of allosteric RdRp blockers that are rigorously vetted from early stage development for their
potential for combination therapy with competitive polymerase inhibitors. In pilot studies, we have engineered a
recombinant HPIV3 reporter virus and identified in a high-throughput screening (HTS) campaign using this
strain two novel, viable HPIV3 polymerase inhibitor scaffolds with sub-micromolar starting potency. Against
RSV RdRp, we have synthetically redesigned an efficacious allosteric measles virus polymerase blocker and
identified in the resulting pharmacophore-informed library a potent new point-of-entry with anti-RSV RdRp
activity. Recognizing the risk of early stage failure in drug development, we have in parallel identified the
protein-protein interface between the RSV polymerase and encapsidated genome as a promising yet
underexplored druggable site. To further diversify the portfolio also of allosteric anti-RSV candidates, this site
will be interrogated with an innovative biochemical HTS assay and orthogonal counterscreens (aim 1). The
existing anti-RSV and anti-HPIV3 leads and newly emerging candidates will be mechanistically characterized
using next-generation cell based and in vitro polymerase assays, and subjected to resistance profiling singly
and in combination with the reference nucleoside inhibitor (aim 2). Allosteric candidates suitable for RdRp-
targeted combination therapy will be synthetically optimized guided by ADME and pharmacokinetic profiles,
followed by animal efficacy and toxicity assessment and synergy profiling in cell culture and in vivo (aim 3).

Public health relevance
Respiratory syncytial virus and human parainfluenzavirus type 3 infections are the leading cause of severe lower respiratory infection of infants in the United States and responsible for a majority of infant hospitalization from infectious diseases. Combined, these related pathogens cause substantial human morbidity and mortality globally in particular among infants, but also the elderly and/or the immunocompromised, and the lack of effective vaccines and small-molecule therapeutics generates high clinical need for the development of innovative therapeutic countermeasures for prophylaxis and improved disease management. Building on an established antiviral program, this project will interface a recently identified nucleoside analog inhibitor of the RSV and HPIV3 polymerase complexes with the development of allosteric polymerase inhibitors to improve public health through novel, highly effective combination therapies.